Serial Killers to Mosquitos: The Spatial Targeting of Larval habitats in rural Uganda using geographic Profiling

PROJECT SUMMARY/ABSTRACT
The widespread deployment of vector control measures, such as long-lasting insecticidal nets (LLIN), has
resulted in significant declines in the global burden of malaria. Yet, these strategies alone are insufficient to
interrupt transmission and sustain gains. Thus, innovations in vector control are urgently needed. Larval source
management (LSM) is the modification of potential breeding habitats to prevent immature mosquitos from
developing into adults, often through the application of larvicides. LSM is, however, resource intensive and
thereby only recommended in select environments. New methods of efficiently locating and targeting
Anopheles breeding sites must be developed to make LSM feasible in a wider variety of settings. Geographic
profiling (GP) was originally developed as an analytical tool in criminology, using the locations of linked crimes
to narrow the search area for likely suspects. GP has been successfully adopted to a number of biological
problems, but in the case of malaria, it has only been applied to a single retrospective data set. Nevertheless,
the model was able to efficiently identify mosquito breeding sites based on the location of clinical cases. My
long-term career goal is to become an independent investigator with expertise in applied epidemiology and
spatial analysis in order to advance our understanding of the geographic factors that influence malaria
transmission and target interventions in the most effective manner. However, to achieve my career goals and
scientific objectives, I need additional mentorship and training in: (i) geographic information science (GISc), (ii)
entomological surveillance, and (iii) molecular epidemiology, all specifically in the context of malaria control. I
will draw upon this training and leverage the resources of my mentors to achieve my scientific objective, which
is to evaluate the effectiveness of a Bayesian GP model to identify Anopheles breeding sites in a low
transmission, highland area of Western Uganda. My central hypothesis is that GP will facilitate the
identification of Anopheles breeding sites without the need for large scale field operations. I will test this
hypothesis by pursuing three specific research aims: (1) establish the accuracy and efficiency of GP to identify
Anopheles breeding sites in comparison to field-based larval surveillance; (2) demonstrate the benefit of
adding the spatial distribution of adult mosquito densities to the GP model; and (3) evaluate the effect of using
a novel, high-throughput sequencing method to exclude imported malaria cases to improve the accuracy of the
GP model. I am well positioned to achieve these aims given the vast institutional resources available to me
through the University of North Carolina at Chapel Hill and the London School of Hygiene and Tropical
Medicine, along with an internationally-renowned team of mentors and advisors, including Dr. Jonathan
Juliano, Dr. Sarah Staedke, and Dr. Steven Le Comber, who pioneered the use of GP to epidemiological
problems. The proposed research is innovative and significant, as the results will represent the first prospective
use of GP to identify mosquito breeding sites, and could make LSM more cost-effective in sub-Saharan Africa.

Public health relevance
PROJECT NARRATIVE Currently employed vector control strategies, including long-lasting insecticidal nets (LLIN) and indoor residual spraying (IRS), can substantially reduce the burden of malaria, but are generally insufficient to achieve and/or sustain malaria elimination. Larval source management (LSM), defined as the treatment of aquatic habitats that are breeding sites for mosquitos, has been a mainstay of historical malaria control programs, but this approach requires sustained field operations that are resource-intensive and currently limit its employment in sub-Saharan Africa. This study seeks to evaluate the use of geographic profiling, a novel spatial analysis tool derived from criminology, to more efficiently identify Anopheles larval habitats, thus making LSM more affordable and feasible in a wider range of settings.